Center for Lupus Research

The Cooperative Center of Research Translation entitled “Center for Lupus Research” (CLR) and
based at Weill Cornell Medicine and JAX/GM aims i) to advance the knowledge of pathways that contribute
to the establishment and amplification of Systemic Lupus Erythematosus (SLE), ii) to identify molecular
mechanisms responsible for failure to respond to standard of care (SOC) therapies, and iii) to develop
assays and tools to monitor these dysfunctional pathways and stratify patients towards personalized
therapies. Understanding major disease pathogenic drivers and identifying biomarkers to follow them in the
clinical setting are highly significant goals to advance clinical trial design and ultimately personalized patient
care. The proposed studies stem from our previous CORT cycle and build on our work uncovering both
molecular heterogeneity and basic mechanisms contributing to the generation of immunostimulatory nucleic
acids (NAs) in this disease. We now provide data supporting that erythroid cells are a novel source of
mitochondrial NAs giving rise to myeloid cell activation and pro-inflammatory loops in children with SLE. In
Project 1, we will dissect the basic mechanisms, pathogenic role and biomarker potential of this novel pathway.
In Project 2, we will capitalize on the groundwork that we have developed over the past 4 years of this CORT
cycle using next generation single cell (sc) transcriptional and epigenetic profiling as well as on our discoveries
of novel gene splice variants expressed in SLE patient immune cells. Both projects will incorporate cutting-
edge technologies and build upon our established expertise in immune profiling. The projects will be critically
supported by collaborations with Clinicians, Molecular and Cellular Biologists, Computer Scientists and experts
in Systems Immunology. The Administrative Core will organize and operate the Center, and assure
communication and interactions among all members and collaborators. The Clinical Core will oversee patient
enrollment and clinical assessment, clinical data collection and sample storage and distribution. Samples
obtained via the Clinical Core will enable the Center scientists to work together and the CLR will ensure
integration of clinical and laboratory data associated with samples across Institutions. The specific aims of the
projects are i) to identify the upstream mechanisms leading to retention of mitochondria in SLE Red Blood Cells
(RBCs); ii) to follow the presence of Mito+ RBCs and their upstream dysfunctional pathways in pediatric and adult
SLE patients during flares and remissions to establish their value as biomarkers and a stratification tool; iii) to
dissect the contribution of erythroid-derived mitochondrial NAs to SLE inflammatory loops; iv) to identify
transcriptional markers of SOC resistance pathways at the single-cell level and to identify isoforms associated
with disease severity and response to treatment; v) to define epigenomic signatures of SLE Disease Activity and
therapy responsiveness, and vi) to characterize the phenotype of therapy-sensitive and resistant Plasmablasts
(PBs) and identify, through functional genomics, the molecules/pathways that confer resistance to therapy.

Public health relevance
P50 Narrative PD: Pascual, V. The Weill Cornell/JAX-GM Cooperative Center of Research Translation entitled “Center for Lupus Research” (CRL) aims i) to advance the knowledge of pathways that contribute to the establishment and amplification of Systemic Lupus Erythematosus (SLE), ii) to identify molecular mechanisms responsible for the failure to respond to standard of care (SOC) therapies, and iii) to develop assays and tools to monitor these dysfunctional pathways. Novel genomic technologies and bioinformatic resources will be used towards these goals, which will advance clinical trial design and ultimately personalized patient care.